Single domain antibody development for improving vascular dysfunction in Alzheimer’s disease

Alzheimer's disease (AD) is the most common form of neurodegenerative disorder associated
with aging. One of the hallmarks of this disorder is the progressive loss of neuronal cells, which
ultimately becomes fatal. Several lines of investigations characterized by the loss of mural cells
(pericytes) and compromised blood-brain-barrier, in pathogenesis of AD. Academic
collaborators and founders of AivoCode Inc., the applicant company, have employed unbiased
screening with in vivo phage display to probe specific vascular signature present in the brains of
transgenic AD mice. This new approach to AD studies has generated a new and understudied
therapeutic target, connective tissue growth factor (CTGF). CTGF binds extracellular matrices
and cell surfaces including brain vasculature in AD mice and can stimulate endothelial cell
migration and angiogenesis. Our preliminary data suggests that CTGF plays a role in causing
abnormalities in AD brain vessels and can potentially be a new therapeutic target for AD drug
development. In this Phase II application, we propose to test single domain antibodies against
CTGF to neutralize CTGF activity in mouse models of AD to improve vascular dysfunction and
test if it leads to slower disease progression. The results of this study will provide a lead single
domain antibody as a drug candidate for further development for AD.

Public health relevance
PROJECT NARRATIVE Vascular dysfunction has been implicated in pathogenesis of Alzheimer’s disease (AD). We have identified a protein CTGF, abundant in AD brains, that possibly plays a role in vascular dysfunction. In this application, we propose to test single domain antibodies for blocking CTGF activity as therapeutic agents to improve vascular defects and slow Alzheimer’s disease progression. This study addresses an underserved medical area, where there is a pressing need for new therapeutic advances.